Spatiotemporal resolution of niche and genomic co-evolution in brain-metastatic organotropism

PROJECT SUMMARY
Brain metastasis (BM) is a feared complication that occurs in patient with multiple advanced cancer types
including melanoma and non-small cell lung cancer and is associated with high treatment resistance, morbidity
and mortality. Extensive genomic profiling of patient tumors has not identified a specific divergent somatic
mutation that determines brain-metastatic organotropism, but in prior studies of patient biopsies, we found that
BMs have a higher degree of chromosomal instability (CIN) compared to extra-cranial metastases across a
variety of cancer types. Using multi-modal single-cell and spatial genomics across multiple cancer lineages, we
have also found a consistent association of CIN and a pro-tumorigenic tumor microenvironment (TME) with BM.
Defining the causal relationship between CIN and BM has previously been challenging due to lack of pre-clinical
models that faithfully recapitulate human disease. Here, we have overcome these barriers, and through
development and implementation of several experimental and technical innovations, are able to model the co-
evolution of cancer cell states and the TME during brain-metastatic progression. Furthermore, we have
assembled unique patient cohorts in which we collected primary tumors and matched BMs from the same
individual, thus, enabling a more accurate evaluation of salient BM biology during metastatic progression in
patients. Building on these, we now propose in Aim 1 to perform spatio-temporal analyses of the entire brain-
metastatic arc, beginning with a single-cell interacting with the blood-brain-barrier, all the way to fully developed
macro-BM. This will be enhanced by using a novel niche-labeling method coupled with spatial transcriptomics,
which will allow for deconvolution of cell-to-cell interactions over time and in space; furthermore, using novel
molecular tools, we will modulate the rate of CIN and test the causal relationship of this genomic feature with the
evolution of an immunosuppressive TME and the rate of BM development. In Aim 2, we will test these concepts
in large NSCLC and melanoma patient cohorts with matched PT and BM, and will employ a series of analytical
innovations to quantify tumor remodel during metastatic progression to the brain. Together, this work will provide
insights into the brain-metastatic cascade through an unprecedented lens, functionally define the role of CIN as
a hallmark of brain metastasis, and enable the dissection of these concepts in unique patient samples. Given
the increasing interest in targeting CIN and enhanced consideration of metastatic disease site in treatment
decisions, this work has important translational implications. With access to world-class mentorship in
bioinformatic analysis and cancer biology at the Columbia University Irving Medical Center, this project will
provide me with a solid foundation for a career as a future physician-scientist in cancer biology.

Public health relevance
PROJECT NARRATIVE Brain metastases are a major cause of cancer-related morbidity and mortality, but the mechanisms underlying their development in humans are poorly understood. Here, we explore genomic and tumor-microenvironmental features of human brain metastases spanning multiple lineages to define shared features that represent hallmarks of brain metastases. Additionally, through development of novel pre-clinical models that recapitulate human biology, we establish the brain-metastatic cascade, allowing us to understand these underlying mechanisms and providing insights critical for the development of more efficient clinical therapeutics.